Asian American Community Cohort and Equity Study (ACCESS)

PROJECT SUMMARY
Between 2000 and 2020, Asian Americans were the fastest growing racial group in the US, increasing from 10.5
million to 24 million individuals. By 2060, the number of US Asians is projected to rise to 46 million, more than
triple their 2000 population. Although Asian Americans (AAs) are commonly viewed as a 'model minority' based
on socioeconomic and health indicators, AAs actually have chronic disease rates that converge with or exceed
those of US whites and are at higher risk for several cardiometabolic disorders despite having lower rates of
obesity. However, due to limited data and the common practice of reporting aggregated data across multiple AA
subgroups, the true extent and nature of the disparities that exist is not well understood. Thus, to address
important gaps in the field, we propose to establish the Asian American Community Cohort and Equity Study
(ACCESS) spanning across the greater Philadelphia-New Jersey-New York City region, which will include 2,400
men and women ages 25-64 drawn from 3 US Asian subgroups: Chinese (n=800), Vietnamese (n=800), and
Filipino (n=800). Our multidisciplinary team will leverage our 22-year established PA-NJ-NYC Regional Network
of collaborative community-based organization partners, clinical providers, city health departments, and
academic investigators to support the cohort’s infrastructure and the recruitment of diverse research participants
with respect to nativity, language, and generational status. With collaboration from our esteemed Community
Advisory Board and Scientific Advisory Board members, our team has a strong and successful record of scientific
productivity and expertise in: 1) the conduct of community-engaged longitudinal cohort studies with AA
populations; 2) rigorous assessment of dietary intake and other health behaviors and lifestyle factors; 3)
standardized measures of social determinants of health (SDoH) and neighborhood-level exposures; 4) collection
of high-quality biospecimens for analysis of biologic markers; and 5) assessment of cardiometabolic outcomes
(e.g., hypertension, type 2 diabetes, cardiovascular disease). The overall objectives of this application are to
establish a rigorous infrastructure of ACCESS including formalizing clinical/community partnerships, developing
cohort infrastructure, and establishing study protocols to support the standardized collection of comprehensive
psychosocial, behavioral, and neighborhood-level data, along with biospecimens and other clinical exams. The
proposed activities are closely aligned with NHLBI’s Strategic Vision and will address key research questions
regarding how the prevalence of cardiometabolic disorders varies across Asian ethnic subpopulations, how
SDoH relates to disease risk in specific subpopulations, and the identification of behavioral and biologic
pathways that may account for individual or group differences in disease risk. This synergistic multidisciplinary
plan to establish a prospective comprehensive cohort that includes 3 large AA subgroups will yield a rich resource
to support rigorous research on multi-level pathways contributing to cardiometabolic disease risk and health
outcomes in these large and growing, but understudied populations that experience significant disparities.

Public health relevance
PROJECT NARRATIVE The proposed project will have a significant and positive impact on the investigation of multi-level sociocultural, behavioral and biologic pathways contributing to cardiometabolic health and disease risk in Asian American subgroups, address how social determinants of health (SDoH) impact cardiometabolic outcomes, and identify key biologic pathways that mediate these associations. Findings will impact public health practice and policy by pinpointing novel or non-traditional risk factors, identifying the most vulnerable populations and subgroups to target for outreach and intervention, and leading to modifications of clinical screening and prevention guidelines for specific AA populations.